Personalized Rejection Risk Assessment in Cardiac Transplantation

Project Summary: Cardiac allograft rejection (CAR) is a serious concern in transplant medicine, representing
the leading threat to short- and long-term allograft survival. As a result, CAR surveillance and prevention is a
primary focus of post-transplant care, with recipients undergoing frequent, scheduled, surveillance endomyocar-
dial biopsy (EMB) for histologic CAR grading along with frequent, scheduled de-escalation of immunosuppres-
sion (IS). The uniformity of this standardized approach to CAR mitigation is the result of an inability to employ
reliable, proactive, and tailored strategies based on individual CAR risk. Consequently, patients at low CAR risk
are exposed to unnecessary EMB procedures and excess IS therapy, while patients at high risk experience
inadequate CAR surveillance and early/inappropriate weaning of IS. This exposes patients to potential harm,
and highlights the clear, unmet need for precision CAR risk-assessment tools. The overarching premise for this
proposal is that contained within the clinical data and EMB tissues already collected as part of usual care at
transplant centers exists the means to provide actionable CAR risk assessments. Extensive immunologic, diag-
nostic, and pharmacologic data are captured in electronic health records (EHR) at transplant centers, while large
collections of EMB histology samples are stored (and often digitized) in pathology archives. This proposal seeks
to utilize advanced machine-learning algorithms and in-situ diagnostic methods to deeply mine these archival
resources for the purpose of validating novel CAR risk-prediction models. In Aim 1, we will leverage our experi-
ence with automated histologic analysis pipelines to develop a ‘morphologic model’ for predicting future CAR
using archived H&E slides. Hematoxylin-and-Eosin (H&E) histology slides are generated from all EMB events
as part of standard-of-care. In published and patented prior efforts, we have extracted quantitative morphologic
features from digitized H&E slides which, when modeled, demonstrate excellent performance for diagnosing
myocardial injury and CAR grades. In Aim 2, we will move beyond standard H&E, leveraging our experience with
quantitative, in-situ immune-profiling of transplant EMBs to develop a ‘morpho-molecular’ model for predicting
future CAR. This aim will expand upon exciting pilot work which showed the CAR risk-stratification potential of
combining quantitative image-analysis with multiplex immunofluorescence. Finally, in Aim 3, we will develop a
‘histo-informatics’ model for predicting CAR by integrating data from Aims 1 & 2 with comprehensive clinical
informatics data extracted from the EHR. Ultimately, as a result of this work, we expect to validate a novel pre-
cision prediction model for use in prospective investigations exploring personalized CAR surveillance and pre-
vention strategies. Beyond the potential translational impact, this research plan will build on the Applicant’s
knowledge of complex cohort design, integrated data modeling, and transplant immunodiagnostics. Along with
planned coursework and a diverse mentoring, advisory, and collaborative team, this proposal provides the opti-
mal vehicle for Dr. Peyster’s maturation into an investigator with proven expertise in multi-modality diagnostics.

Public health relevance
Project Narrative: There is considerable uniformity in the rejection surveillance and prevention protocols used in heart transplant medicine, primarily due to a lack of precision diagnostic tools for assessing individual rejection risk. The inability to provide personalized immunosuppression and biopsy schedules that are tailored to individual risk exposes patients to serious and avoidable opportunistic infections, procedural injuries, and rejection events. This proposal aims to apply advanced informatics, computer-vision, and in-situ diagnostic methods to archived clinical data and biopsy tissues in order to develop a rejection risk-prediction model capable of improving precision in post-transplant care.